AACR Conference on The Science of Cancer Health Disparities in Racial/Ethnic Minorities and the Medically Underserved

PROJECT SUMMARY
The proposed conference series, titled “The Science of Cancer Health Disparities in
Racial/Ethnic Minorities and the Medically Underserved,” will be held annually in the fall
(2024-2028). The locations of the 2024-2028 conferences remain to be selected but will be
chosen based on several factors in including proximity to minority-serving institutions and
communities impacted by cancer disparities as well as the future needs and growth of the
conference series. This proposed conference series will be the 17th-21st in an AACR series
focused specifically on the science of cancer health disparities. The first conference on The
Science of Cancer Health Disparities in Racial/Ethnic Minorities and the Medically Underserved
was held in 2007, then annually from 2009-present.
While many conferences on cancer health disparities focus on policy and public health issues or
one specific underserved group, the goal of this conference is to feature the full spectrum of
research in the field and incorporate presentations on a wide range of medically underserved
populations while including perspectives from basic, population, behavioral, computational,
translational, and clinical researchers in conjunction with those from patient advocates,
government, public health experts, and others. Transdisciplinary interactions and collaborations
will be pivotal to advancing the field, stimulating new research, and making progress in reducing
and ultimately eradicating cancer health disparities.
Additionally, this conference series serves as a platform to facilitate the development of a
diverse cancer workforce and to provide educational opportunities to clinicians treating
medically underserved patients. Professional development opportunities for early career
investigators are available at all levels of the conference from experience as session chairs and
program committee members to poster presentations and mentored roundtable discussions.
CME credits are available for clinicians seeking to increase their knowledge and skills in
providing treatment to ethnic/racial minorities and medically underserved patients.

Public health relevance
PROJECT NARRATIVE Analysis of cancer incidence and mortality data underscores the disproportionate impact of cancer in specific racial, ethnic, and medically underserved groups. These disparities arise from a complex interplay of several elements including socioeconomic, cultural, systemic, biological, and genetic factors. This conference series serves as a platform for bringing together basic scientists, physicians, behavioral researchers, population scientists, healthcare experts, and members of the community to encourage interdisciplinary collaborations, foster the development of a diverse cancer workforce, and ultimately make substantial progress in eradicating disparities in cancer.